1/2 PROSpect: Prone and Oscillation Pediatric Clinical Trial (CCC)

Project Summary Although acute respiratory distress syndrome is a life-threatening and frequent problem experienced by thousands of children each year, little evidence supports best ventilation practices during their critical illness. For over 25 years, pediatric critical care clinicians have debated the risk-benefit ratio of supine versus prone positioning and conventional mechanical ventilation (CMV) versus high-frequency oscillatory ventilation (HFOV) in the management of these young patients. Without pediatric-specific data, the debate of how best to care for children with severe Pediatric Acute Respiratory Distress Syndrome (PARDS) will continue and prevent progress in the field of pediatric critical care. We propose PROSpect (PRone and OScillation PEdiatric Clinical Trial), a two-by-two factorial, response- adaptive, randomized controlled clinical trial of supine/prone positioning and CMV/HFOV. Forty-five pediatric intensive care units (PICUs), 30 U.S. and 15 international (2/3:1/3 split), with at least 5 years of experience with prone positioning and HFOV in the care of pediatric patients with severe PARDS, that can provide back- up extracorporeal membrane oxygenation (ECMO) support will participate. Eligible consecutive subjects with severe PARDS will be randomized within 48 hours of meeting eligibility criteria and within 4 days of endotracheal intubation to one of four groups: supine/CMV, prone/CMV, supine/HFOV, prone/HFOV. Subjects who fail their assigned positional and/or ventilation therapy for either persistent hypoxia or hypercapnia may receive the reciprocal therapy while being considered for ECMO cannulation. Our primary outcome is ventilator-free days (VFD), where non-survivors receive zero VFDs. We hypothesize that children with severe PARDS treated with either prone positioning or HFOV will demonstrate ≥2 more VFDs. Our secondary outcome is nonpulmonary organ failure-free days. We will also explore the interaction effects of prone positioning with HFOV on VFDs and also investigate the impact of these interventions on 90-day in-hospital mortality and, among survivors, the duration of mechanical ventilation, PICU and hospital length of stay, and the trajectory of post-PICU functional status and health-related quality of life (HRQL). Up to 1000 subjects with severe PARDS will be randomized by age group and direct/indirect lung injury. Adaptive randomization will begin after 400 subjects provide complete data on VFDs. Any group demonstrating inferiority at a pre-planned adaptive randomization update analysis will be eliminated to increase allocation to the superior group(s). Data will be analyzed per intention-to-treat and per-protocol received. This clinical trial will provide the definitive evidence necessary for the field to consider a major change in clinical practice in the care of critically ill children with severe PARDS.

Public health relevance
Project narrative Acute respiratory distress syndrome is a life-threatening and frequent problem experienced by thousands of children each year. Little evidence supports current supportive practices during their critical illness. The overall objective of this study is to identify the best positional and/or ventilation practice that leads to improved patient outcomes in these critically ill children.